Interrogating the Clonal Architecture of Human Hematopoiesis by Mitochondrial Lineage Tracing

Project Summary
During aging, human hematopoietic stem cells decline in function, with consequences including
cytopenias, increased risk of blood cancer, and decreased regenerative capacity.1–3 Along with
other intrinsic and extrinsic changes, somatic mutations that accumulate in individual stem cells
have been recognized as a major contributor this process.4,5 Some of these mutations convey
fitness advantages, resulting in clonal expansion; this phenomenon, termed clonal
hematopoiesis, is present in the majority of people past the age of seventy, and has been
associated with increased risk of blood cancer and cardiovascular disease, partially attributed to
a pro-inflammatory cellular environment.2,6–8 Along with somatic variation driving clonal
expansion, high-penetrance inherited genetic variants also cause impactful changes to the
clonal composition of hematopoietic stem cells during the lifespan. Interestingly, rare inherited
Mendelian mutations in RUNX1 which cause RUNX1 Familial Platelet Disorder are associated
with an extremely high incidence of clonal hematopoiesis and overt leukemia.9–13 To date, the
interplay between these germline and somatic mutations driving HSC clonal expansion and the
pro-inflammatory microenvironment in which the clones expand is not fully understood, nor is it
known how these changes collectively drive the functional decline and increased morbidity
associated with clonal hematopoiesis in humans.14 In this grant, I propose to map the
disruption of the clonal architecture of human hematopoietic stem cells driven by
high-effect somatic and germline variants, and identify the phenotypic changes by which
this results in impaired stem cell function and increased disease risk with aging. Aim 1
proposes to extend the mitochondrial lineage tracing methodology we have developed in the
Sankaran laboratory to call nuclear DNA variants. Aim 2 will use these methods to define at high
resolution the changes in the overall clonal architecture observed during human aging, and
identify the causative interactions between inflammatory signaling, somatic mutations, and
clonal expansions in hematopoietic stem cells during aging. Aim 3 will examine the alterations to
hematopoietic clonal structure caused by RUNX1 germline mutations, and how these alterations
contribute to the observed hematopoietic dysfunction and increased leukemia risk observed in
RUNX1 Familial Platelet Disorder. These studies will reveal mechanistic insights into how
hematopoietic clonal structure changes across the lifespan and the consequences for
hematological function and disease.

Public health relevance
Project Narrative During the lifespan, hematopoietic stem cells acquire mutations and expand into clonal populations, driving increased risk of cancer, cardiovascular disease, and overall mortality. The mechanisms underpinning the expansion of these mutation-carrying stem cells and their phenotypic consequences remain poorly understood. The proposed research will apply mitochondrial lineage tracing and deep phenotypic characterization of hematopoietic stem cells in the setting of RUNX1 Familial Platelet Disorder and during aging to identify fundamental biological principles governing clonal expansions, inflammatory changes to cells, and downstream phenotypic consequences, with the hopes of identifying important pathways underpinning the observed decreased hematopoietic function and increased cancer risk in these settings.